Novel regulators of Gli-driven medulloblastoma

0-$"!!1.2*8/%3#!4"5!$6!!&8'%!9%%#6#"1!5!*6$*!!#+#!4#$%"$$!#$!$#'!'!!**&"!&$$!!*"!$!$$$(!$"!#!56%#'"7!0+$!&#$,!&!!&"!$!&!#3!#!#$$**#$!#!%#$"!!!%&+!"*!#!!4&%#0$!1#)$23%"&!**!'*!!$"*#&%"$*+",!%!&
!#!$#&#%#"#!!C$$#*"#"##%!$%"!!!!!"*!9!32#!&$$**'%#$!#!"8##!"!+43##!!!2**$!B2'%$!!!:#'$;!)<!&!!$!#!%(!*'!C!!*!*=>""!@=@#A!
E

Public health relevance
The identification of novel druggable targets in SHH driven cancers has remained a major challenge in the field. To tackle this obstacle we have identified a novel set of such targets, using a focused siRNA screen, a candidate approach, or a proteomics approach. The goal of this proposal is to characterize a subset of such regulators and to validate their roles in vivo, using mouse and human orthotopic mouse models of MB.